Alliance for Clinical Trials in Oncology Operations Center - GY11 Funded Extension

Contact PD/PI: Piantadosi, Steven
PROJECT SUMMARY
The Alliance is an experienced multi-institutional cancer clinical trials group that has been reorganized in
response to the IOM consensus report and NCI directives for cooperative group reorganization. Alliance provides
a comprehensive and highly efficient clinical trials infrastructure, access to experienced collaborators across all
disciplines of oncology clinical trials research, and a diverse portfolio of trials for patients with breast,
gastrointestinal, genitourinary, respiratory, central nervous system, hematological malignancies, and selected
rare tumors. Particular strengths of the Alliance include the long-standing tradition of collaborative research of
the legacy members, including many who have participated in cooperative group research since its inception in
1955.
The Mission of the Alliance for Clinical Trials in Oncology is to reduce the impact of cancer by:
• Conducting high quality multidisciplinary cancer control, prevention, and treatment trials that engage a
comprehensive research network;
• Furthering our understanding of the biological basis of the cancer process and its treatment; from
discovery, to validation, to clinical practice;
• Providing a scientific and operational infrastructure for innovative clinical and translational research in
the academic and community settings.
Project Summary/Abstract

Public health relevance
Contact PD/PI: Piantadosi, Steven PROJECT NARRATIVE/RELEVANCE To reduce the impact of cancer on people by uniting a broad community of scientists and clinicians from many disciplines, committed to discovering, validating, and disseminating effective strategies for the prevention and treatment of cancer. Project Narrative